Analytical Core

PROJECT SUMMARY: Analytical Core
Polychlorinated biphenyls (PCBs) are important Superfund chemicals that are human carcinogens also
associated with neurological and metabolic disruption. The Analytical Core (AC) supports all five ISRP projects
in generating high-quality research products, including data, standard operating procedures, and peer-
reviewed publications that are standardized, efficient, and comparable across all ISRP matrices and projects.
Centralizing instruments, equipment, standards, protocols, and training under the AC provides significant
savings to the ISRP. The AC will continue to accomplish these activities through five Specific Aims: Aim 1.
Maintain analytical quality assurance standards and protocols. Accurate, precise, representative, reproducible,
and comparable sample analysis is essential for all five ISRP projects and is a key AC objective. The rigor of
the Quality Assurance protocol for PCB analysis provides a critical foundation for discoveries by the ISRP
projects. Aim 2. Facilitate high-throughput analysis of complex biotic and abiotic matrices. The AC supports
ISRP projects during sample analysis for all 209 PCBs and 124 OHPCBs as MeO-PCBs in complex matrices,
including: air, sediment, soil, water, porewater, laboratory animal tissues, microbial cultures, and building
materials. Aim 3. Provide prioritized training and resources. The AC, in collaboration with the Research
Experience and Training Coordination Core, provides prioritized, standardized training in AC facilities and
methods to graduate student and postdoc trainees, faculty, and staff from all ISRP projects. Aim 4. Support
method development for complex matrices, analytical methods, and data analysis. The AC, in collaboration
with ISRP projects, will continue to develop, maintain, and update extraction and instrument analysis methods
for high-throughput PCB and OH-PCB extraction and analysis in biotic and abiotic samples. Comparable
methods are maintained across matrices to facilitate integrated data analysis. Aim 5. Maintain analytical
infrastructure for novel and routine analysis. The AC maintains critical infrastructure, including high-use
equipment, separate laboratories for high and low PCB concentration environmental samples and animal
tissues sample extraction, and separate cold storage for standards, sample and sample extracts, and clean
media. The AC, in collaboration with the Data Management and Analysis Core, provides oversight to make
data findable, accessible, interoperable, and reusable (FAIR). Overall, the AC is a fully-integrated support core
that assists ISRP projects to meet all four SRP mandates requiring methods for identifying human health
hazards of superfund chemicals, detection, assessment of exposure risk, and remediation.

Public health relevance
NARRATIVE: Analytical Core The Analytical Core (AC) provides analytical services to the Iowa Superfund Research Program to facilitate high-quality research on toxic polychlorinated biphenyls (PCBs). The AC provides instrumentation and facilities, quality assurance standards and protocols, training, and support for method development. The Analytical Core aims are relevant to the mandate of the Superfund Research Program because they will enable accurate, precise, representative, reproducible, and comparable sample analysis that is essential to the success of the innovative studies proposed by all five ISRP research projects.